Targeting epigenetic regulation via Bromodomain and Extraterminal (BET) domain inhibition for treatment of GVHD

Abstract
Acute Graft-versus-Host Disease (aGVHD) occurs due to donor T cell alloreactivity against host tissues and is
the major cause of non-relapse mortality after allogeneic stem cell transplantation (alloSCT). Approximately
50% of patients are not responsive to front-line corticosteroid therapy and deemed “steroid-refractory” with
limited to no effective standard therapies. Our long-term research goal is to identify and evaluate innovative
approaches to improve patient outcomes by preventing and/or abrogating aGVHD toxicity post-alloSCT. The
proposed research presents pioneering clinical and translational approaches to target epigenetic regulation of
inflammatory mediators via Bromodomain and Extraterminal (BET) domain inhibition using novel non-
benzodiazepine structured PLX (51107 and 2853) to prevent and mitigate aGVHD. PLX boasts improved
pharmacokinetic and tolerability profiles to benzodiazepine-scaffolded BET inhibitors. We observed that BET
inhibition with PLX results in potent suppression of T cell proliferation and pro-inflammatory cytokine secretion
of IFN-g, IL-6, and TNF-α without affecting T cell viability. Our data also demonstrate that BET inhibition with
PLX significantly downregulates transcription of T cell costimulatory genes, major inflammatory cytokines, and
cell-cycle regulators. Importantly, we identified that BET inhibition decreases T cell proliferation and dampens
inflammation independent of STAT-1. Thus, we targeted JAK/STAT blockade with the recently FDA approved
JAK1/2 inhibitor ruxolitinib and observed synergistic effects of dual BET and JAK1/2 inhibition on T cell
proliferation. We hypothesize that BET inhibition with PLX is a feasible, effective strategy to mitigate T cell
mediated aGVHD inflammation as a single agent. Further, we propose preclinical analyses to assess the
synergistic mechanisms and tolerability of dual BET/JAK1/2 inhibition. Aim 1 of the proposed research tests
our hypothesis in a Phase 1b/2 proof-of-principle clinical trial for patients with steroid-refractory aGVHD with
single agent PLX51107. Correlative studies are designed to assess 1) response to therapy and 2) immune
reconstitution of T cell subsets. In Aim 2, we will use preclinical models of aGVHD to test the hypothesis that
BET inhibition results in improvement in aGVHD survival by downregulating Th1 and Th17 pathogenic T cell
responses while maintaining Treg mediated tolerance. We observed a very strong reduction in expression of
Th1/Th17 pro-inflammatory genes such as IFN- g, IL-17 and IL-2 as well as co-stimulatory molecule CD40L
with PLX treated T cells in vitro. We propose to analyze the effects of PLX on individual T cell subsets and their
implications in aGVHD pathogenesis in vivo. Aim 3 will 1) test the hypothesis that dual BET and JAK1/2
inhibition will reduce GVHD and prolong duration of treatment response; and 2) assess the effects of
combination therapy on Treg and effector T cell function. These experiments will determine the future
applicability of T cell subset directed therapy for aGVHD as well as inform the development of future clinical
trials combining BET and JAK1/2 inhibition for aGVHD prevention or treatment indications.

Public health relevance
Project Narrative Acute Graft-versus-Host Disease (aGVHD) is a common and frequently lethal complication, occurring in >50% of allogeneic stem cell transplants, limiting survival and the success of a curative therapy for hematologic diseases. The proposed study will examine the underlying effects of Bromodomain and Extraterminal (BET) domain inhibition on T cell and dendritic cell immunobiology both in preclinical and clinical studies and assess synergy of dual BET/JAK1/2 inhibition for treatment of aGVHD. Our studies will determine the safety and feasibility of a novel therapy for steroid-refractory aGVHD and establish the biological rationale for single agent and combination therapy for future clinical studies.